Human 3D neuro-muscular assembloids to study cell tropism and host factor utilization of divergent neuropathogenic enteroviruses

PROJECT SUMMARY
Enteroviruses are the leading cause of viral meningitis in children and recent outbreaks of emerging non-polio
enteroviruses (NPEVs) have been associated with a polio-like paralysis named acute flaccid myelitis (AFM).
Discovery and characterization of cellular components that are critical for neuropathogenesis hold promise for
revealing new approaches to treat enterovirus disease. In recent years, multiple receptors have been identified
for EV-A71 and EV-D68, NPEVs, which are most commonly associated with AFM. Using unbiased genome-
scale screens, we have identified the phospholipase PLA2G16 as an entry factor acting immediately
downstream of receptor engagement following NPEV infection. How the multiple receptors and PLA2G16 work
together to enable infection in cell types relevant for neuropathogenesis is, however, largely unknown. Infection
of cell types present in the central nervous system is critical for developing severe neurological forms of
disease following infection with NPEVs. Although mouse models have been widely used to gain insights into
enterovirus infection processes, genetic and physiological differences between human and rodents limit their
translational potential. Moreover, species incompatibilities in host factor interactions of these human
enteroviruses necessitate overexpression of human receptors, mouse-adapted strains or neonatal infections.
In work that forms a foundation for this proposal, we have developed from pluripotent stem cells human spinal
cord organoids that recapitulate some of the cell diversity of the human spinal cord. Importantly, we have
pioneered an approach to functionally connect motor neurons in spinal cord organoids with human skeletal
muscle and cortical neurons in a preparation we named assembloids. These motor assembloids form
functional neuro-muscular junctions and can control muscle contraction. Here, we propose to systematically
study the role of known host factors in cell lines derived from neural tissue on EV-A71 and EV-D68, discover
novel host factors by performing unbiased genome-scale genetic screens in neural cell lines, and compare cell
lineage tropism and effect on neuronal function during enterovirus infections of cortico-motor assembloids.
Our results will reveal the role and relative contribution of a distinct set of critical receptors and broad-acting
host factors to infection by multiple enteroviruses, discover and provide details on the molecular mechanism of
novel host factors in neural cell types, and leverage a unique neural organoid system to uncover the specific
tropism and functional effect on human neural-muscular circuits during infections with the paralytic
enteroviruses EV-D68 and EV-A71.

Public health relevance
PROJECT NARRATIVE Enteroviruses are ubiquitous pathogens causing a number of important human diseases including respiratory disease, hand foot and mouth disease, myocarditis, and acute flaccid myelitis. Outbreaks of non-poliovirus enteroviruses such as EV-D68 and EV-A71 cause severe neuropathology in children. Our contributions will have wide-reaching impacts as the identified cellular genes and molecular mechanisms are likely to provide new targets for therapeutic interventions, in addition to fundamentally advancing the fields of viral neuropathogenic disease modeling and stem cell engineering.